GASTROINTESTINAL DISEASE TRAINING GRANT

DESCRIPTION The goal of the University of Colorado School of Medicine Training Program in Gastroenterology and Hepatology is the development of physician scientists who will assume full-time academic-research positions in the fields of digestive and liver diseases. Six trainee positions are requested, an increase from the four presently funded. The training faculty has 34 members: eight from the Gastroenterology-Hepatology Division (two with joint appointments in basic science departments), 25 from other divisions and departments in the School of Medicine, and one from a collaborating institution. The Principal Investigators states that since submission of the last competitive renewal, a net addition of twelve funded, experienced investigators have been made to the training faculty. The faculty members' research interests are in four broad interest areas: nutrition; immunology/intestinal infection-inflammation; hepatobiliary pathophysiology; and gastrointestinal oncology/epithelial growth regulation. According to the application, the program emphasizes: the selection of trainees from a wide variety of backgrounds and who have a confirmed commitment to research-academic careers; exposure of the trainees to a broad selection of preceptors and integrated training opportunities; and close supervision and direction of the trainees' career development.